Perfluoroalkyl substances and non-alcoholic fatty liver disease in children: Leveraging magnetic resonance imaging to unravel potential mechanisms and exposure mixture effects

PROJECT SUMMARY
Non-alcoholic fatty liver disease (NAFLD) is the most prevalent liver disease globally. In the U.S., almost 30% of
adults, and over 10% of children are estimated to have NAFLD facing increased risk for long-term complications,
such as liver failure, hepatocellular carcinoma, extrahepatic comorbidities, and need for liver transplantation in later
life. NAFLD is more prevalent in Asian countries, however Asians are underrepresented in previous NAFLD studies
in the U.S. and elsewhere. Per- and polyfluoroalkyl substances (PFAS) are high-priority pollutants that
bioaccumulate and persist in the environment and human tissues, such as the liver. Existing evidence from
experimental models shows hepatotoxic effects caused by PFAS exposure, such as altered lipid metabolism,
hepatic steatosis, and more advanced stages of NAFLD. There findings are in line with recent prospective
epidemiology studies that have reported associations between prenatal PFAS exposures and multiple adverse
metabolic outcomes. However, no previous study has utilized novel magnetic resolution imaging technologies that
permit the quantification of fat and lipid content in the target liver tissue, and therefore can establish a causal link
between PFAS and NAFLD. Moreover, human evidence is lacking to elucidate the potential interplay between
PFAS exposures and well-established metabolic and genetic risk factors in NAFLD etiology. We hypothesize that
prenatal exposure to PFAS promotes liver steatosis and injury in children (Aim 1) via alterations in lipid and amino
acid metabolism (Aim 2), and that these effects are stronger in children who have higher genetic and/or metabolic
susceptibility to NAFLD (Aim 3). To test these hypotheses, we will leverage the unique, existing, population-based
mother-child cohort ‘Growing Up in Singapore Towards Healthy Outcomes (GUSTO)’ in Singapore with
comprehensive assessments of pre- and perinatal PFAS exposures in maternal and cord serum, non-invasive
proton magnetic resonance spectroscopy (MRS) measures of liver fat content and targeted metabolomics in 530
children aged 6-7.5 years, as well as extensive genome-wide, metabolic phenotype, lifestyle and relevant covariate
data from longitudinal follow-up examinations. This is the first and most comprehensive study on PFAS exposures
and pediatric NAFLD using state-of-the-art liver MRS imaging, metabolomics, environmental exposure mixture,
and polygenic risk score approaches to determine the interplay of environmental, genetic, and metabolic risk
factors in NAFLD. Findings will contribute to establish a causal link between PFAS exposures and pediatric NAFLD
and inform early-life prevention and interventions strategies sorely needed to address the current NAFLD epidemic.

Public health relevance
NARRATIVE We will investigate the association of exposure to per- and polyfluoroalkyl substances (PFAS) with the risk for non-alcoholic fatty liver disease in 530 children from Asia to elucidate the potential impact of PFAS on liver disease, underlying mechanisms and gene-environment interactions. To achieve this, we will utilize state-of-the- art magnetic resonance imaging, high-resolution metabolomics and genomic approaches. Findings from this study will yield valuable insights for the impact and interaction of environmental, metabolic and genetic risk factors in pediatric NAFLD and inform early-life prevention and intervention strategies.